Structural basis of apoptotic scrambling

ABSTRACT
Every day ~50 billion cells undergo apoptosis, or programmed cell death. Efficient recognition and clearance of
these cells is critical for tissue homeostasis in physiology and for its recovery following disease. Initiation of the
apoptotic cascade triggers activation of phospholipid scramblases that externalize the lipid phosphatidylserine
(PS) in the outer leaflet of the plasma membrane. Recognition of PS by dedicated receptors (PSRs) on immune
cells is the first and critical step in the clearance of apoptotic cells. Immune cells with activated PSRs create an
immunosuppressive environment that can be exploited by pathogens exposing PS in an immune-camouflage
strategy called apoptotic mimicry. Recent studies implicated members of the XKR protein family in apoptotic
scrambling. Dysfunction of XKR proteins results in an inflammatory environment and autoimmune disorders
while their uncontrolled activation favors oncogenesis and facilitate viral entry. Thus, it is critical to elucidate the
molecular mechanisms of XKR function and regulation to understand their physiological roles and their
association with pathology. Currently, only structures of non-functional XKR proteins are available, hindering our
understanding of how these protein mediate PS externalization. In preliminary experiments we show that two
XKR homologues, CED-8 from C. elegans and human XKR4, scramble lipids. Using cryogenic electron
microscopy, we determined the 3.55 Å resolution structure of hXKR4 in a novel, likely active conformation,
providing insights into a potential mechanism for lipid transport. In our 1st aim, we propose to determine the
structures of hXKR4 and CED-8 in different conformations and functional states to determine the molecular
bases of XKR activation. We will use our newly developed biochemical assays to probe and elucidate the
functional implications of these structures. The physiological implications of these mechanisms will be tested in
cell-based measurements. Our 2nd aim is to determine how XKR proteins scramble their surrounding membrane
lipids. Using cryoEM we will directly visualize the hXKR4 and CED-8 scramblases in the context of a membrane
to determine how they interact with and remodel the surrounding bilayer to enable lipid scrambling. Furthermore,
we will investigate how changes in the physicochemical properties of the membrane support different functional
states of these proteins. Our 3rd aim is to elucidate the regulatory mechanisms of XKR activity. Using in vitro
and cell-based functional assays, we will determine whether and how hXKR4 and CED-8 are directly regulated
by cellular factors, such as processing by apoptotic caspases, phosphorylation, or interactions with of a peptide
derived from the nuclear DNA repair protein XRCC4. Collectively, our studies will lay the foundation for future
investigations of the molecular underpinnings of the XKR scramblases in vivo.

Public health relevance
NARRATIVE The XKR proteins play a central role in the transport of the phosphatidylserine lipid to the external surface of dying (apoptotic) cells, where it acts as the key cue for their recognition and clearance by immune surveillance cells. Despite recent progress in elucidating the structure of XKR proteins, our ability to recognize their functions in human physiology and to design targeted pharmacological interventions is limited by our poor understanding of the mechanisms that regulate their activity. The goal of our project is to overcome these limitations by determining how the XKR proteins transport these lipids and how their activity is regulated in cells.